HYPERTROPHIC CARDIOMYOPATHY--FAILURE TO DEMONSTRATE MUTATIONS IN EXON 13

Familial hypertrophic cardiomyopathy (FHCM) has been linked to the cardiac beta-myosin heavy-chain (MHC) genes on chromosome 14 (14q1), and a missense mutation within exon 13 of the beta-MHC gene has been implicated in the pathogenesis of the disease. To test whether this constitutional mutation occurs somatically in the myocardium of the sporadic form of the disease, we studied seven patients with familial (n=3) or sporadic (n=4) hypertrophic cardiomyopathy (HCM). Amplification of exon 13 of the beta-MHC from paraffin-embedded myocardium using the polymerase chain reaction (PCR) was performed and analysis of the amplified product for migration abnormalities using denaturing patients with HCM nor subjects with dilated cardiomyopathy (DCM) (n=2) exhibited an aberration within exon 13 of the myocardial beta-MHC. It is concluded that a specific beta-MHC gene mutation is displayed only in a subset of patients with familial disease, thus further emphasizing the notion of genetic heterogenecity. In addition, in the sporadic form of the disease, somatically occurring mutations in this particular exon could not be demonstrated.